Antidepressants and Intracellular Signaling Linked to BDNF

Project Summary
In the previous funding period we investigated the mechanism of rapid antidepressant activity of ketamine, an
ionotropic glutamatergic n-methyl-d-aspartate (NMDA) receptor antagonist. We demonstrated that Brain-
derived neurotrophic factor (BDNF), and its high affinity receptor TrkB, are required for the rapid
antidepressant effects of ketamine as these effects are lost in forebrain specific BDNF knockout mice and
conditional forebrain specific TrkB knockout mice. We found the antidepressant effects of ketamine require
protein translation, but not transcription, resulting in increases in BDNF protein levels in the hippocampus that
are critical for the behavioral effect. Ketamine's blockade of spontaneous NMDA receptor mediated
neurotransmission inactivates eukaryotic elongation factor 2 kinase (eEF2K) resulting in dephosphorylation of
its only known substrate, eukaryotic elongation factor 2, thereby increasing protein translation of target
transcripts, including BDNF. In turn, BDNF is postulated to act via eliciting insertion of 3-hydroxy-5-methyl-4-
isoxazolepropionic acid (AMPA) receptors at the postsynaptic membrane, which results in potentiation of
AMPA receptor-mediated CA3-CA1 field excitatory postsynaptic potentials (fEPSPs) by ketamine. While this
potentiation is suggested to be a cellular correlate of rapid antidepressant effects, its properties deviate from
classical Hebbian forms of plasticity and rather coincide with homeostatic synaptic scaling seen after activity
suppression. These data provide the basis for the novel hypothesis that BDNF-TrkB signaling regulates
synaptic scaling in vivo that is critical for the rapid antidepressant effects of ketamine. The objective of this
renewal is to specifically test the causal and instructive role of BDNF-TrkB signaling in the hippocampus in
ketamine-mediated synaptic scaling and rapid antidepressant effects. Collectively, this information will provide
novel information on the synaptic locus, as well as key molecules, necessary for ketamine's rapid
antidepressant effects.

Public health relevance
PROJECT NARRATIVE The objective of this grant is to study the role of BDNF in the hippocampus in regulating homeostatic synaptic plasticity critical for mediating antidepressant responses in mice. Based on our preliminary data presented in this application, we will examine the impact of BDNF specifically in the hippocampus on homeostatic synaptic scaling in vivo in rapid antidepressant responses. These studies will use molecular, cellular, behavioral, and electrophysiological approaches to investigate whether BDNF is sufficient to drive synaptic scaling in vivo and mediate fast-acting antidepressant responses, in the hopes of developing novel antidepressants with rapid onset of clinical efficacy.